Integrative analysis of human placental epi/genome in relation to fetal growth

The goal of this proposal is to integrate multi-scale epi/genomic placental molecular features and relate this
to fetal growth to provide mechanism insight into the contribution of the placenta to the Developmental
Origins of Health and Disease (DOHaD). I am a molecular epidemiologist with a primary research interest
in understanding inter-individual differences in disease risk and how early-life exposures can influence
these differences. In the K99 phase, I trained in integrative genomics and bioinformatics, early-life
epidemiology, and placental biology and pathology with the help of my mentors and advisors Drs. Ke Hao,
Jia Chen, Carmen Marsit and Dr. Harvey Kliman. The aims of this research are: 1) to construct an
integrative epi/genomic catalogue of term placentas; 2) to characterize cell-type specific DNA methylome
and transcriptome to construct a cell-type reference panel for human term placenta and 3) to evaluate the
influence of placental molecular features on birth weight. In this proposal, I leverage existent epi/genomic
and epidemiological data from the Rhode Island Birth Cohort Study and placental cell-type specific
epi/genomics profiles with the overarching goal of mapping placental molecular features involved in birth
weight and DOHaD. The knowledge gained through this research has the potential to inform more broadly
on the influence of the intrauterine environment on health throughout the lifespan and develop placental
biomarkers to inform disease prevention.

Public health relevance
The proposed research will develop an integrative placental tissue and cell sub-populations epi/genomic catalogue. This research has the potential to advance our understanding of the placental contribution to fetal growth and lay the groundwork to develop placental biomarkers to inform individual disease risk.